Dissecting and targeting canonical and non-canonical oncogenic functions of EZH2 in caner

PROJECT SUMMARY/ABSTRACT
Leukemia patients bearing MLL1 rearrangement generally display very poor prognosis, demanding new
treatment strategies. Multiple independent studies have identified EZH2, a histone methyltransferase and
catalytic subunit of Polycomb Repressive Complex 2 (PRC2), as an attractive drug target in MLL1-rearranged
leukemias. However, the current catalytic inhibitors of EZH2 have limited anti-tumor effect. Our preliminary
studies show that EZH2 also binds c-MYC and has a non-canonical function in activation of oncogenes (such
as Cyclin E1) in MLL1-rearranged leukemias, which differs from the well-known PRC2:EZH2-driven canonical
function related to gene repression. In order to target both canonical and non-canonical oncogenic actions by
EZH2, we used the Proteolysis Targeting Chimera (PROTAC) technology to generate novel EZH2 small-
molecule degraders including MS177. Our extensive preliminary studies have demonstrated that MS177
effectively degrades both PRC2:EZH2 and non-PRC2 partners of EZH2 (e.g., c-MYC, which binds EZH2 to
activate oncogenes), thus suppressing both canonical and non-canonical oncogenic activities of EZH2 in
tumor. Importantly, our preliminary results also show that MS177 is superior to all of enzymatic inhibitors of
EZH2 in treating MLL1-rearranged leukemias. Thus, we hypothesize that: (1) EZH2 has a less-studied, non-
canonical oncogenic function, which acts in parallel with the PRC2:EZH2-dependent one to produce more
aggressive tumor phenotypes seen in MLL1-rearranged leukemias; and (2) targeting both canonical and non-
canonical activities of EZH2 by PROTACs represents a novel and superior therapeutic strategy to inhibition of
EZH2’s enzymatic activity alone. Dissection of the mechanisms underlying EZH2-mediated oncogenesis and
development of an optimal EZH2 PROTAC as a drug candidate will have significant impact on improving
treatments for MLL1-rearranged leukemia patients. Towards this goal, we will further characterize such a new
non-canonical oncogenic role of EZH2 in MLL1-rearranged leukemias (Aim 1a) and define effects of EZH2
PROTACs on suppressing both canonical and non-canonical oncogenic activities of EZH2 (Aim 1b). We will
also determine in vitro and vivo therapeutic effects of EZH2 PROTACs by employing multiple independent
MLL1-rearranged leukemia models including human/murine cancer cells and patient-derived xenografts (PDX)
(Aim 2). Lastly, we will optimize our EZH2 PROTAC leads into a drug candidate (Aim 3). Completion of the
proposed research will not only provide novel mechanistic understanding of how MLL1-rearranged leukemias
develop, but will also validate an innovative therapeutic strategy and deliver a promising therapeutic candidate
for the treatment of affected cancer patients.

Public health relevance
PROJECT NARRATIVE Patients with MLL1-rearranged acute leukemia exhibit particularly poorer clinical outcomes, demanding effective treatments. This proposal aims to characterize a previously unknown non-canonical oncogenic function of EZH2, which contributes to aggressive tumor phenotypes, and develop a novel therapeutic strategy and generate a promising drug candidate for treating MLL1-rearranged leukemias. Therefore, the proposed research is directly relevant to public health.